Brain Network based Language System Neuromodulation for Aphasia

ABSTRACT
Patients with stroke affecting left hemisphere brain regions commonly develop aphasia - major language deficits
highly limiting their quality of life. Key to developing novel, targeted treatments for these deficits is better
understanding how the brain manages the many cognitive processing demands of language, including semantic
demands, which relates to understanding word meanings. These include the ability to retrieve a word with the
right meaning from memory or the ability to select the right word from those of similar meaning. While
neuroimaging and stroke lesion studies have revealed which isolated brain regions underlie language ability,
little is known about how complex interactions between these brain network regions contribute to semantic
cognition for language production. The proposed research uses network control theory (NCT), an emerging
branch of systems engineering computation applied to neuroimaging - to model cortical brain regions and their
white matter tract connections as a network of nodes and edges, respectively. NCT quantifies the properties of
anatomical brain network structure that can constrain and control cognitive dynamics that drive complex human
behaviors like language production. In Aim 1, I will study how brain network controllability influences healthy
language production, and how an individual’s network control characteristics predict language behavior changes
after manipulation by focal neuromodulation. Specifically, we used repetitive transcranial magnetic stimulation
(rTMS) to experimentally modulate brain connectivity in healthy adults, to discover which language network
topologies control word selection and retrieval during open-ended language generation tasks. In Aim 2, I apply
these NCT methods in people with chronic post-stroke aphasia, to determine brain network predictors of optimal
semantic responses to rTMS, using data from a completed clinical trial of rTMS for language recovery. The
proposed work will be carried out in the world class training environment at the University of Pennsylvania’s
Laboratory for Cognition and Neural Stimulation. These resources combined with an expert sponsorship team,
including experts in studies of aphasia, network control theory and neuromodulation, will fully support completion
of this proposal and facilitate my professional development as a future physician-scientist leading rigorous and
reproducible clinically relevant research. Ultimately, the results of my proposed work will be key to improving the
efficacy of noninvasive neuromodulation by personalizing therapies for aphasia rehabilitation - and will provide
an advanced understanding of the neural basis of language more broadly.

Public health relevance
NARRATIVE Stroke is a leading cause of disability in the United States, often leading to acquired language deficits, or aphasia, which affects one’s personal and financial wellbeing through barriers to social and professional participation. While current standardized behavioral treatments can promote limited recovery, personalized neural treatments are sorely needed to improve efficacy and promote long-term recovery. This research on the brain network basis of language in healthy and stroke patients will enable prediction of individual responses to transcranial magnetic stimulation (TMS) - improving treatment efficacy for future clinical translation as a promising aphasia therapy.